Core A: Administrative Core

PROJECT SUMMARY
The Administrative (Admin) Core will provide research and logistical oversight and facilitate communication
among the Projects and Cores of the Prospective Genetic Risk Evaluation and Assessment (PROGRESS) in
Autism Center. The Admin Core’s goal is to foster a PROGRESS Center environment that allows for the
complementary and synergistic execution of the proposed multidisciplinary research that will identify and partner
with a cohort of families whose children are at identified genetic risk (IGR) for autism (Project 1), understand the
impact of this genetic information on parents and families (Project 2), and examine neurobehavioral trajectories
of PROGRESS Cohort children across development (Project 3). In addition to supporting these three Projects,
the Admin Core will support the other Core Components: the Assessment Core, the Statistical and
Computational Analysis (SCA) Core, and the Dissemination and Outreach (D&O) Core. The Admin Core will
have three main functions. The first function is scientific leadership and integration, providing programmatic
governance to maximize synergy, efficiency and impact of our research. The Admin Core leadership is
composed of the Executive Committee (Center Director and Co-Director, Director of Operations, Director of
Finance, and a Program Coordinator) and a Steering Committee (all Project and Core Leads and Co-Leads).
Admin Core function includes programmatic coordination of the Center Research Projects and Cores, strategic
planning of short- and long-term goals, and ethical considerations of the implications of our genomic research.
Secondly, the Admin Core will provide management to deliver centralized administrative, fiscal,
organizational, and communications coordination of the PROGRESS Center. The Projects and Cores span
Columbia University, the New York State Psychiatric Institute, and Weill Cornell Medical Center, thus requiring
central governance and organization that will be provided by inter-institutional coordination and communication
by the Admin Core. Finally, the Admin Core will ensure added value and scientific rigor of the PROGRESS
Center Research Projects and Cores through Center Evaluation. The Admin Core will interface with an
External Advisory Committee (EAC) of experts in fields relevant to autism research. The Admin Core will respond
to recommendations made by the EAC, as well as recommendations made by a Community Advisory Board
(CAB) to address scientific and community concerns and increase the PROGRESS Center’s national and global
influence on scientific and clinical practice. The Admin Core will therefore provide seamless integration of the
various PROGRESS Center Components at multiple sites to produce high quality and meaningful data that will
aid in early identification and management of identified genetic risk for developing autism.